CHAIRS-C: Climate, Health, and Aging Innovation and Research Solutions for Communities

Greenhouse gas emissions and anthropogenic air pollution are changing the climate, creating complex spatial
and temporal interactions that threaten health on a global scale. The existing literature has addressed the main
effects of extreme temperature or air pollution on human health primarily with spatially coarse exposure
estimates and without considering their interactions. The result is that environmental epidemiology on the
health impacts of extreme heat and air pollution for aging populations is often out of date and likely
underestimates these effects, in an era when our climate is increasingly unstable. Recent advances in satellite
remote sensing and machine learning to predict ground conditions present a key opportunity to enable
comprehensive study of the multifaceted effects of climate on healthy aging. Leveraging this opportunity, the
CHAIRS-C Research Project will combine advanced spatiotemporal exposure modeling with national Medicare
data, already in use at Brown, for case-crossover epidemiologic analyses. Our team combines expertise in
environmental epidemiology, pharmacoepidemiology, big data health services research, and advanced
biostatistical modeling. The long-term objectives of this project are to improve the quantification of the health
impacts (emergency department visits and hospitalizations as well as all-cause mortality) associated with
short-term extreme temperature, specific humidity, and fine particulate (PM2.5) air pollution on aging
populations; identify vulnerable subpopulations; and construct a framework for the comparison of medications
that increase the occurrence of climate-related illnesses. These results will help improve targeted public health
interventions and may lead to actionable medication adjustments that modify the adverse effects of climate-
related exposures. To achieve these objectives, the project will pursue the following specific aims: 1)
Estimating the climate-related health impacts for older adults by linking new best-available temperature,
specific humidity, and PM2.5 exposure estimates with Medicare records for aging populations, using a case-
crossover design; 2) Quantifying the sensitivity to climate-related exposures within susceptible subpopulations
to prioritize public health interventions with a particular focus on social determinants of health that contribute to
climate-related health disparities; and 3) Examining comparative effect modification attributable to target
medication classes on heat-related events, using propensity-score matching for medication selection within a
case-crossover analytic framework for health effects. This 3-year research project is nested within the
collaborative infrastructure of CHAIRS-C and will establish a platform for further solutions-oriented
interdisciplinary research and community engagement. Constructing national place-based linked datasets for
temperature, humidity, and PM2.5, as well as social determinants of health, demographic covariates, chronic
conditions, pharmaceutical prescriptions, and the quantification of impacts on hospitalization and death in the
Medicare population will further accelerate innovative research in climate change and healthy aging for all.